The University of North Carolina Center for AIDS Research

PROJECT SUMMARY/ABSTRACT – OVERALL UNC CFAR
The UNC Center for AIDS Research is a consortium of three interactive and local institutions: UNC Chapel Hill
(UNC), Research Triangle Institute International (RTI), and Family Health International 360 (FHI 360). This
consortium of interactive research communities has existed since the CFAR was formed in 1998. The UNC
CFAR is notable for the breadth of research activity, the high level of excellence of its member researchers, and
the importance of its domestic and international partners in fighting the HIV epidemic. The CFAR consists of 8
cores (Administration, Developmental, Clinical, Clinical Pharmacology and Analytical Chemistry, Biostatistics,
Social and Behavioral Science, International, HIV/STD Laboratory), and within the Administrative Core the
SCEED Office (Strategic Communication, Engagement, Education, and Dissemination). In addition, the CFAR
supports one Scientific Working Group: North Carolina (NC) Collaborative HIV Epidemiology and Prevention,
partnering with the NC state health leaders; and three Research Interest Groups (RIGs): HIV and Criminal
Justice, Technology and Engagement, and Carolinas United to End HIV (CUE-HIV). The CUE-HIV RIG is an
inter-state (North and South Carolina) and inter-institute partnership that represents a unique approach to bring
together partners in jurisdictions where there is no CFAR to answer the Federal Government’s call to End the
HIV Epidemic. The CFAR is focused on supporting research in the important targeted areas of: 1) Ending the
HIV Epidemic 2) Cure/Eradication 3) Co-morbidities, Co-Infections and Complications 4) Prevention (including
TasP and combination prevention) 5) Antiretroviral treatment and pharmacology 6) HIV and Cancer 7) HIV and
high risk populations (Transgender women, Adolescents, Young men who have sex with men) 8) HIV and the
Brain and 9) Behavioral and Social Sciences research to help address disparities. The CFAR has strong
institutional support, which greatly enhances our capacity to support the wide range of research activities of our
membership. Due to ongoing institutional support, the efforts of our membership, the hiring of new faculty, and
the work and investments of the CFAR, we have seen a 51% increase in our funded research base over the
most recent 5-year period. Commensurate with this growth in the research enterprise, CFAR members hold
important positions of leadership within the three CFAR collaborating institutions and across the NIH networks.
Thus the UNC CFAR represents a critical component of a strong, growing, and dynamic consortium of
researchers who are collectively working to change the course of the HIV epidemic.

Public health relevance
PROJECT NARRATIVE – OVERALL UNC CFAR The UNC Center for AIDS Research provides essential infrastructure support for the wide range of HIV related research for its members. This research contributes to the major goals of Ending the HIV Epidemic and HIV prevention and cure, and has overarching public health impact.